Multiethnic machine learning brain signatures of ADRD

PROJECT SUMMARY / ABSTRACT
The underlying pathology of Alzheimer's disease and related dementias (ADRDs) accumulates gradually over
decades, making the identification of non-invasive, sensitive biomarkers in the preclinical stage a critical public
health priority. Harnessing advanced analytic methods, our team and others have established neuroimaging
signatures of advanced brain aging (Spatial Pattern of Atrophy Recognition of Brain Aging, SPARE-BA) and
functional decline (fSPARE-BA), and ADRDs (SPARE-AD and SPARE-Small vessel disease), which predict
incident cognitive decline. Unfortunately, most research to date has been conducted in predominantly non-
Hispanic white populations, which limits the ability to generalize results to the diverse ethnoracial makeup of the
United States' growing aging demographic. If current trends continue, machine learning models will primarily be
trained in ethnically imbalanced datasets, leading to biases that may affect clinical relevance. Thus, the primary
aims of the current proposal are to: leverage an ethnically diverse neuroimaging consortium to build new machine
learning models trained by data from ethnically well-balanced populations, derive sensitive and specific
neuroimaging signatures of brain aging and ADRD, and evaluate whether they can be practical non-invasive
biomarkers of incident cognitive decline, mild cognitive impairment (MCI), and dementia across ethnoracial
groups. We propose to leverage the rich clinical and neuroimaging (structural MRI and resting-state functional
MRI) data within the Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium,
including the Atherosclerosis Risk in Communities Study (ARIC), the Cardiovascular Health Study (CHS), the
Genetics of Brain Structure and Function Study (GOBS), the Framingham Heart Study (FHS), the Vascular
Contributions to Cognitive Impairment and Dementia consortium (MARK-VCID) and the Multi-Ethnic Study of
Atherosclerosis (MESA). We will leverage a collaborative research framework across existing longitudinal
cohorts to address unanswered questions contributing to disparities in ADRD burden. Machine learning
algorithms will be applied to brain imaging data of over 7,200 non-Hispanic Whites, 1,400 Blacks, and 1,425
Hispanics to address our Specific Aims: 1) Generate and evaluate clinical utility of machine learning-based
signatures of brain aging and ADRD for each race/ethnic group and uncover multidimensional heterogeneity in
aging across groups; 2) Examine associations of vascular risk factors with the derived machine learning-based
brain signatures of ADRD by race/ethnicity, and 3) Explore blood-based biomarker predictors of these machine
learning-based brain signatures by ethnoracial group to elucidate underlying biological mechanisms. Further, we
will share our robust machine learning models together with implementation software with the scientific
community. This project will develop and validate neuroimaging markers with robust predictive utility for incident
cognitive decline and to identify underlying pathophysiologic pathways, expanding opportunities for novel
intervention development across diverse ethnoracial cohorts.
ii

Public health relevance
PROJECT NARRATIVE As the US population ages, Alzheimer's disease) and its related dementias (ADRD) are responsible for ever- increasing morbidity, mortality, and health care costs. Unfortunately, little research has examined factors relevant to ADRD in non-white individuals. Using data from the Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium, made up of 6 large and long-term NIH-funded cohorts with racially diverse participants, we will build new ethnically diverse machine learning models, derive novel neuroimaging machine learning-based brain signatures of ADRD from them, and evaluate their clinical relevance across diverse ethnoracial groups. iii